Emotion dynamics and alcohol use in NIAAA-defined recovery from alcohol use disorder

Project Summary
Recovery from Alcohol Use Disorder (AUD) is comprised of two factors: (1) cessation of
heavy drinking and (2) remission from a DSM-5 AUD diagnosis (NIAAA, 2021). Recognizing
both the chronicity of AUD and high relapse rates, recovery is a process that unfolds over time
and is categorized based on duration: initial (up to 3 months), early (3 months to one year),
sustained (1-5 years), and stable (5 or more years). Across these different recovery durations,
negative affect (NA) is a common precipitant of relapse or return to a non-recovery status
(Lowman et al., 1996; Marlatt & Gordon, 1985; Witkiewitz & Villarroel, 2009). However, most
studies examining the relationship of negative affect and relapse report only mean levels of
negative affect. Emotion dynamics, including negative affect variability and emotion
differentiation, have been shown to provide additional, unique information not captured in mean-
level estimates (Colgan et al., 2019; Erbas et al., 2021; Jenkins et al., 2020). Information
provided by emotion dynamics can provide a more nuanced understanding of how negative
affect impacts recovery status and how affect regulation may vary as a function of recovery
duration. Ultimately, knowledge of how emotion dynamics operate in NIAAA recovery may
assist with identifying optimal timing of intervention and re-intervention during different recovery
durations
In order to better to understand the relationship of negative affect variability and alcohol
recovery, this study proposes to recruit individuals in each of the first 3 recovery durations (e.g.,
initial, early, and sustained) who have achieved cessation of heavy drinking and remission from
a DSM-5 AUD diagnosis and thus meet NIAAA criteria for AUD recovery. By combining a
baseline assessment with 28 days of EMA reporting, it is possible to study the relationship of
emotion dynamics to alcohol consumption in AUD recovery and explore covariates that may
help to explain this relationship.

Public health relevance
Project narrative: This project will test for differences in emotion dynamics (e.g., within-day negative affect variability and emotion differentiation) across NIAAA recovery (e.g., cessation of heavy drinking and remission from DSM-5 AUD) phases examine associations between amotion dynamics and alcohol consumption between and within NIAAA recovery phases. Study findings have the potential to provide critical information that can serve to identify optimal timing of intervention and re-intervention during different recovery periods, prepare patients for affective changes that may occur during AUD recovery, and inform longitudinal studies that examine trajectories of relapse and recovery in the long-term.